A tunable laser scanning system for rapid analysis of biopharmaceutical formulations

Project Summary
The goal of this Direct to Phase II SBIR proposal is continue development of Nirrin’s proprietary tunable
laser spectrometry system in preparation for commercialization. Biomanufacturing at commercial scale requires
precise monitoring of product components, including active pharmaceutical ingredients (APIs) such as proteins,
peptides, and nucleic acids, but also supporting excipients which are essential for overall safety and efficacy.
Process errors can lead to incorrect concentrations of APIs and excipients leading to extremely costly process
revisions and millions of dollars of waste in the form of adulterated product. Nirrin Technologies, Inc. has
developed the NXT platform, a rapid and sensitive instrument for the simultaneous analysis of biopharmaceutical
APIs and excipients from a single sample with zero up-front sample preparation. The system relies on tunable
laser spectrometry, scanning samples across multiple wavelengths and compiling absorbance spectra unique to
the given analyte. Absorbance spectra have been developed and validated for dozens of biopharmaceutical
API’s and excipients and can be rapidly analyzed via Nirrin’s straightforward software user interface. The NXT
workflow has been evaluated by multiple biopharmaceutical companies and satisfies many of the key product
requirements which competing technologies do not.
An foreseen challenge with the current Phase II project is the need for validated standards to be used for
customer validation as well as post-installation quality assessment. Aim 1 has been largely completed, optimizing
system design, however, Aim 2 will significantly benefit from the supplement proposed here. Often reagents
generated by customers have significant errors from batch to batch, and so highly controlled standards must be
generated. The company has previously relied on NIST-validated reagents; however many customers are using
custom reagents that are not available in NIST-qualified aliquots. Supplemental funding is therefore requested
to acquire quantification instrumentation for both protein (Repligen SoloVPE System) and small molecules
(Agilent HPLC). These will be used to test standards, as well as produce sets of qualified dilution series for
multiple reagents for aim 3 external validation at customer sites.

Public health relevance
Project Narrative Manufacturing biopharmaceuticals relies on bioprocessing which is comprised of multiple steps including synthesis of components, purification to remove contaminants, and the addition of supporting excipients in very precise concentrations. Ensuring that products are consistent from batch to batch is not only essential to safety and effectiveness but is required by regulatory agencies such as the Food and Drug Administration. Biopharmaceuticals found to be out of compliance can lead to massive costs for manufacturers to dispose of the adulterated product, as well as rebuild bioprocessing practices to eliminate errors in the future. Nirrin has developed the NXT system, a tunable laser spectrometry system which has been evaluated by numerous biopharmaceutical companies for bioprocessing quantitation of APIs and excipients. Here, we will optimize the system, prepare it for commercialization and perform an external validation study, testing the system’s capabilities at multiple biopharmaceutical manufacturers.